Administrative Core

Abstract: Administrative Core
During the next 5 years, the USC ADRC proposes to continue its focus on vascular contributions to cognitive
impairment and Alzheimer’s disease (AD), vascular and metabolic risk factors (VMRF), the neurovascular unit
(NVU), and relationship with AD biomarkers (β-amyloid and p-Tau), brain structure and function and cognition
(Overall aim 1); to provide infrastructure for ADRC-affiliated research studies and USC investigator-initiated
clinical trials (Overall aim 2); and contribute expertise in vascular disease, biomarkers, and imaging to national
initiatives (Overall aim 3). The Administrative Core will provide the leadership, administrative mechanisms and
oversight to enable our ADRC to achieve its overall aims. By providing a clear and transparent mechanism for
communication, resource allocation, budget management and insuring all regulatory and patient safety
processes are adhered to, the Administrative Core will further the overall missions as described in each of the
other components of this proposal. In the next funding cycle the ADRC will actively follow 650 participants (25%
Latino), with the intention of enriching for high VMRF (66%) and availability of cerebrovascular phenotyping using
neuroimaging and biofluid biomarkers (e.g., DCE-MRI, OCTA, TCD, vascular molecular biomarkers). The ADRC
will continue to provide infrastructure and expertise for ADRC-affiliated research studies, USC investigator-
initiated clinical trials, and multi-center clinical studies and trials. Our development projects will continue to
engage and recruit USC faculty and their trainees into AD research at USC. The ADRC will continue contributing
expertise in vascular disease, biomarkers and neuroimaging to collaborative national initiatives directly 1)
through participation in the National Alzheimer Coordinating Center (NACC), National Centralized Repository for
AD (NCRAD), Alzheimer Disease Genetics Consortium (ADGC), Alzheimer Disease Neuroimaging Initiative
(ADNI), and the Alzheimer Clinical Trials Consortium (ACTC); and 2) via several ADRC-affiliated national and
international independently-funded studies such as LONI, ADNI, Human Connectome project, GAAIN, ENIGMA
Consortium, and multi-institutional national and international programs currently validating our new imaging and
biofluid vascular biomarkers.